DEI Summer Research Program

Research teams with diversity among the members are shown to be more effective than homogeneous teams.
However, many persons from disadvantaged minority groups may not be aware of career opportunities in
biomedical sciences. We hypothesize that exposure to science as a career needs to be early such that
students can prepare themselves for such a career. To that end, in 2021 the Research Service of the
Oklahoma City US Department of Veterans Affairs Medical Center partnered with Langston University to offer
a summer research experience to under-represented minority undergraduate students. Langston, founded as
part of the 2nd Morill Act of 1890 as a land-grant college. is located about 30 miles from the OKC VAMC main
campus in Oklahoma City, and is Oklahoma’s only and the nation’s most westerly Historically Black University.
Virtually all undergraduate students at Langston are culturally identified as Black Americans, and many are
from poor and rural backgrounds, and many are the first member of their family to attend college.
Subsequently, in collaboration with Langston and our academic partner the Oklahoma Medical Research
Foundation, which is immediately adjacent to the OKC VA, we obtained funding for a 3-year summer research
pilot program for under-represented minority students. This program was highly successful, not only the
research experience but our evaluation of the program. Based on the latter we implemented several well
received changes such a journal club to train students to search, read and interpret medical literature as well
as preparatory sessions to train students in fundamental lab techniques and ethics. We also incorporated
minority students from the US military academies into the program in 2023 (and will do so in 2024). Based on
our success in the pilot program, we plan on continuing the collaboration with Langston and OMRF with a 5-
year award with the hypothesis that the best method to learn about biomedical research is to do it. Our aims
are as follows. First, provide a hands-on summer research experience to Langston University undergraduates.
Second, provide a summer research experience to under-represented undergraduate at the US military
academies with the hypothesis that these students may be highly likely to service their country in the VA
system. In a third specific aim, we will provide educational session complementing the practical experience in
order to enhance students ‘soft skills’ such as speaking and presenting, and understanding biomedical
literature. Our summer research program will allow students to not just to experience but perform biomedical
research such that these students can make an informed decision about their future career goals.

Public health relevance
Diversity in teams of researchers is shown to enhance the work done by these groups. However, many students from under-represented minorities do not know much about careers in biomedical research. Collaborating with Langston University, the most westerly and Oklahoma’s only Historically Black University, the Oklahoma City US Department of Veterans Affairs Medical Center Research Service has offered and will to continue to offer a summer research experience to Langston undergraduates. We think the best way to learn about research is to do it. So, these students will have a hand-on experience performing biomedical research. In this the students will not only learn about the particular problem under their study but also learn about research in general, especially how they might pursue research in their future career.